Novel Relationships between BER Glycosylases and Mutagenic DNA Adducts

Hypoxanthine (Hx) is a major DNA lesion generated by deamination of adenine during chronic inflammation, which is an underlying cause of various diseases including cancer of colon, liver, pancreas, bladder and stomach. There is evidence that deamination of DNA bases induces mutations, but no study has directly linked Hx accumulation to mutagenesis and strand-specific mutations in human cells. For the first aim, I examined the frequency, type, and distribution of mutations that result from hypoxanthine incorporation in human normal HEK293 cells, and in cancer HCT116 cells. I found that Hx is a major DNA lesion that causes large scale deletions, A:T→G:C transition mutations, insertions, and variation of mutations in the leading and lagging strands of DNA. This is the first report of direct evidence of mutagenic potential and mutation patterns of Hx in live human cells. Furthermore, I have also found that Hx, previously thought to be only repaired by N- methylpurine DNA glycosylase (MPG), is also excised by 8-oxoguanine DNA glycosylase (OGG1). For the remainder of my thesis (Aim 2) I will seek to investigate Hx’s prevalence in normal and cancerous human tissue. I will also examine OGG1’s role in the excision and repair of Hx through various biochemical characterizations. Upon completion of my PhD (Aim 3), I would like transition to a post-doctorate position investigating radiation, DNA damage, and cancer incurred during long duration spaceflight.

Public health relevance
Chronic inflammatory conditions potentiate the risk of cancer by damaging DNA and other sensitive biomolecules. This research examines inflammation product hypoxanthine (Hx), a DNA modification involving the deamination of adenine, and characterizes the mutagenic effects that occur as a result. The goal of this study is to spotlight the mutagenicity of Hx and its relationship with DNA repair glycosylases OGG1 and MPG in HAP1 cells, and human normal and cancer tissues.